Cancer Center Administration

PROJECT SUMMARY/ABSTRACT–Cancer Center Administration The Office of Administration is the organizational hub that advances and supports the activities of the St. Jude Comprehensive Cancer Center (SJCCC). It provides resources and expertise to facilitate the initiatives and ongoing operations of the Center, including providing the crucial organizational structure and support to enable leadership to bring to life a robust 8-goal SJCCC strategic plan in the current project period. The administrative team is led by Ms. Dana Wallace, Associate Director for Administration, who directs and facilitates all processes for strategic planning and oversees all operations of the Office of Administration. Ms. Wallace is joined by a team of expert administrators and works closely with the SJCCC Director, Associate Directors, Program Co-Leaders, and Shared Resource Directors to plan and execute the strategic goals of the Center, fiscally manage the CCSG and provide comprehensive administrative oversight and support for the Center. Administration effectively oversees the CCSG application process and ensures accurate, comprehensive reporting; manages and tracks membership processes; and manages space, budgets, pilot awards, and Shared Resources to fully support Center members in advancing their research programs. Administration also organizes and supports meetings, strategic plan working groups, and other forums to promote transdisciplinary team science within the SJCCC and with external investigators. During the current project period, Administration worked with the Center Director to develop and execute the year-long strategic planning process that involved all members of the SJCCC, 4 retreats, and numerous follow-up meetings, ultimately leading to 8 strategic goals that expand Center capabilities, exciting new research areas, and outreach and career enhancement activities. Administration also planned and operationalized changes in membership policy to ensure support of a cancer research-centric membership, developed proposals for Leadership consideration to implement recommendations from the SJCCC advisory committees, and planned, developed, and administratively supported substantial new initiatives in community engagement and outreach such as the St. Jude Science Scholars of Tomorrow Symposium and HPV Awareness Task Force. During this period, the SJCCC Office of Administration increased by 3 FTEs to accommodate the increased activities generated by strategic planning and the vision of the Center Director. Future plans include further growth in administrative staff to support ongoing growth of Center activities, and building upon the current processes for strategic plan implementation in collaboration with the Director and Senior Leadership, with a focus on developing and implementing action plans to accelerate progress. We will also support SJCCC members in competing for extramural funds by identifying and communicating relevant funding opportunities and organizing training activities to complement our successful grant-writing workshops. Through these efforts, Center Administration provides support for the SJCCC and its members in our shared mission of advancing research and cures for pediatric cancer.